Function of sphingoid bases in brain health and disease

Project Summary
Sphingolipid metabolism is fundamental for the function of the nervous system. Mutations in the enzymes of
sphingolipid metabolism lead to severe neurological disorders such as sphingolipidoses and hereditary
neuropathy, underscoring the essential roles of sphingolipid metabolism in the brain. Ceramide synthase 1
(CerS1) is the main neuronal isoform of the enzyme that synthesizes the common precursor for all sphingolipids,
i.e., ceramide. Catalytically inactive CerS1 mutations in human and mice lead to serious neurological disorders,
myoclonic epilepsy with mental retardation and cerebellar neurodegeneration with ataxia. Our previous work has
shown that neurotoxicity in CerS1 deficiency is due to the increased levels of sphingolipid bases,
dihydrosphingosine and sphingosine and their phosphates, dihydrosphingosine-1-phosphate and sphingosine-
1-phosphate. Importantly, increased levels of the sphingolipid bases were shown in complex neurological
disorders such as Alzheimer’s disease. A critical knowledge gap and barrier to progress is the lack of a thorough
understanding of the mechanism underlying toxicity of those sphingolipid metabolites.
To address this shortcoming, we developed an innovative transgenic mouse model to investigate the mechanism
underlying sphingoid base-induced neurotoxicity in neurodegenerative diseases. In this transgenic model, a
different ceramide synthase isoform, CerS2, is ectopically expressed in the neurons of the CerS1-deficient mice.
The CerS2 transgene rescued the neurodegenerative phenotype and restored the physiological levels of the
sphingoid bases and phosphates. The levels of the individual ceramide species in the CerS2 transgenic, on the
other hand, were the same as in the CerS1 mutant. Using this mouse model, we will pursue complementary in
vivo and in vitro approaches to dissect autonomous neuronal effects of sphingoid bases elevation on gene
expression and sphingolipid metabolism from trans-effects on glia, both of which can contribute to
neurodegeneration.
In this proposal we will address the hypothesis that neuronal homeostasis of sphingoid bases and their
phosphate derivatives is essential for neuronal health and, if dysregulated, induces neuronal dysfunction and
activation of glia. We will: a) test that upregulation of the brain levels of sphingoid bases and phosphates in
CerS1-deficient mutant mice alters the transcriptomes of neurons and glia over time by affecting neuronal
maturation leading to defective neuronal differentiation and the activation of glia (Aim 1); b) test how CerS1
deficiency and sphingolipid base upregulation in neurons affect their intracellular membrane and lipid trafficking
(Aim 2); and c) test that neuronal-induced sphingoid base phosphate signaling leads to the activation of glia (Aim
3).

Public health relevance
PROJECT NARRATIVE: The role of biosynthesis of sphingolipid precursors for brain health is not well understood. Our preliminary data demonstrated that accumulation of the sphingolipid precursors, the sphingoid bases and their phosphate derivatives, results in neuronal damage and activation of glia leading to neurodegenerative disease. We are proposing to use unique mouse models to study the role of the sphingoid bases and their phosphate derivatives in brain health and disease.